Core-001

Coordination and communication between the three Research Projects and two Scientific Cores
is essential to ensure the smooth operation of the program, advance overall scientific progress, and
support the dissemination of research findings. The Administrative Core plays a critical role in the overall
program through leadership, supervision, and support for each of the component Projects and Cores.
The specific functions of the Administrative Core are: 1) to oversee and foster communication among the
scientists involved in the individual Projects and Cores; 2) to coordinate periodic review of the Program
Project by external advisors; 3) to coordinate financial, regulatory, and scientific reporting to NIAID and
other supervising authorities; and 4) to coordinate publication of scientific results and data sharing with
the research community.